Understanding health disparities in Pakistani, Bangladeshi and Asian Indian immigrants: the role of socio-cultural context, acculturation and resilience resources - Supplement

SUMMARY
The objective of the parent R01 Mediators of Atherosclerosis in South Asians Living in American (MASALA)
study is to identify how socio-cultural context, discrimination, acculturation strategies and resilience resources
act as risk or protective factors explaining cardiovascular health (CVH) disparities in Indian, Pakistani and
Bangladeshi immigrants. MASALA is a longitudinal study that involves participants completing a physical
exam, survey, and providing biospecimens. The parent study includes a qualitative component (Aim 3) to
“conduct in-depth interviews to elucidate how South Asian immigration experiences influence acculturation
strategies, resilience resources, and CVH.” While these in-depth interviews will provide important insights into
participant lives, the interviews may miss seminal moments that shaped their life trajectory and health status.
For South Asians in particular, there are historical (e.g., partition, Bangladesh war of independence, migration
out of South Asia) and contemporary sources (e.g., family dynamics, discrimination) of trauma. Building on Aim
3 of the parent grant, Dr. Naheed Ahmed’s diversity supplement application will use a life history interview
methodology to apply a trauma informed lens on lifetime sources of distress related to migration, violence,
discrimination, acculturation, socioeconomic status, and family dynamics with a sub-set of MASALA
participants (N=20) interviewed for Aim 3. Participants will be selected based on depressive symptoms from
the CES-D scale (low symptoms: <16 vs. high symptoms: ≥16). These life history interviews will provide rich
data on the lived experiences of participants, and how historical and contemporary events shaped their current
situation and health status. Participants, who complete a life history interview, will be invited to attend a
storytelling workshop to learn how to share aspects of their lives through creative mediums. After attending the
workshop participants will be invited to share their storytelling project in a community forum organized by the
study team. Research has demonstrated that storytelling as a public health intervention has the potential to
increase group cohesion, support, and promote healthy behaviors. The specific aims of this study are: Aim 1:
Deepen our understanding of intergenerational and lifetime trauma on depressive symptoms among South
Asians in the MASALA study by conducting life history interviews with 20 participants that have either low or
high depressive symptoms; Aim 2: Conduct a storytelling workshop using a strengths-based approach for
participants to share aspects of their life history interviews from Aim 1 for social and emotional support; and
Aim 3: Evaluate the feasibility and acceptability of storytelling as a mental health intervention using qualitative
approaches, and the Reach, Efficacy, Adoption, Implementation, Maintenance (RE-AIM), and social and
behavioral change models.

Public health relevance
PROJECT NARRATIVE The objective of the parent R01 Mediators of Atherosclerosis in South Asians Living in American (MASALA) study is to identify how socio-cultural context, discrimination, acculturation strategies and resilience resources act as risk or protective factors explaining cardiovascular health disparities in Indian, Pakistani and Bangladeshi immigrants. The proposed diversity supplement application will enhance the parent grant using life history interviews to gain an in-depth understanding of the lived experiences of participants, and how historical and contemporary trauma has shaped their health status. A storytelling workshop and community forum to share these stories will be used to assess the feasibility and acceptability of storytelling as a mental health intervention.